Single molecule DNA/RNA sequencing technology based on a parallel Raman scattering readout in a coupled nanochannel/nanopore system

Single molecule DNA/RNA transport and Raman sequencing technology based on parallel Raman
scattering readout in a coupled nanochannel/nanopore system.
Abstract
Armonica Technologies, Inc. is proposing to develop a novel, high-throughput, label-free, highly
accurate, long-read DNA sequencing platform based on inexpensive nanoscale patterning and self-
assembly. The platform consists of nanochannels (cross section dimensions of ~ 100nm); tortuous
(convoluted 3D) nanopores formed by self-assembly of colloidal nanoparticles; nanoparticle barriers
placed across the nanochannels; and a metal-insulator-metal (MIM) field enhancement structure atop the
nanochannel roof. In operation, single- stranded- or double-stranded-DNA is partially stretched into a
linear configuration in the nanochannels, is blocked at barriers incorporated into the channels and forced
(by electric field) to translocate through the tortuous nanopores in the roof. The MIM structure on the roof
locally enhances the electromagnetic fields of applied laser sources allowing surface enhanced coherent
anti-Stokes Raman scattering (SECARS) detection of individual bases as they pass through the
electromagnetic hot spots, thus providing single base sensitivity and spatial localization. The distinct
Raman spectra of the individual bases and epigenetic variants allow label-free sequencing. Optical
detection allows massively parallel operation since the only requirement is separation of the pores by
more than an optical wavelength, easily accomplished in the fabrication. An important feature of the
platform is that the porous roofs allow introduction of oligonucleotides, small proteins, and DNA-
binding/DNA-processing enzymes, permitting optional manipulation and modification of the DNA in the
nanochannels. The goals of this Phase II project are: to develop a protocol for electrophoretic control of
the ssDNA translocation; to engineer the structure to ensurethat the ssDNA passes the MIM hot spot; to
sequence a short section of ssDNA and evaluate error rates; and to develop parallel optical readout, AI
analysis of the data and appropriate storage protocol.

Public health relevance
Single molecule DNA/RNA sequencing technology based on a parallel Raman scattering readout in a coupled nanochannel/nanopore sequencing system. Project Narrative: Rapid, label-free, highly accurate, long-read DNA sequencing has important implications for genomic and medical applications. A novel nanostructured platform consisting of nanochannels, tortuous (convoluted 3D) nanopores, nanopore barriers along the nanochannels and metal-insulator-metal (matamaterial/plasmonic) antennas is proposed. Sequencing of the DNA is by label-free surface- enhanced Raman scattering, an highly specific process that identifies epigenetic chemical modification and does not require labeling or amplification, simplifying the sequencing flow, and, most importantly allowing processing of cellular DNA with minimum pre-preparation. The optical readout enables massively parallel sequencing with dramatically faster throughput than current technologies.